Neural Circuit Mechanisms Mediating TMS and Oxytocin Effects on Social Cognition

We are requesting an increase in the yearly direct costs to support the aims of the MERIT renewal. What we
propose is a dramatic leap into the future of social neuroscience and lies at the bleeding edge of current
technology. The proposed research is innovative, ambitious, and necessary for understanding how primate, and
by extension human, brains enable appropriate social behavior in the real world. Our proposal advances
understanding of how primate brains generate appropriate social behavior through a tightly-integrated, ambitious
set of 4 specific aims combining simultaneous wireless neurophysiological recordings in multiple freely-moving
monkeys interacting naturally in varied social contexts, semi-to-fully-automated quantification of social behavior
using computer vision, pharmacological manipulations, and reversible perturbations of neural activity. To our
knowledge, none of these experiments has ever been attempted in macaques. Our pilot data compellingly
demonstrate that we can do it.